Patient reported outcomes in patients with nontuberculous mycobacterial pulmonary disease

PROJECT SUMMARY/ABSTRACT
Nontuberculous mycobacteria (NTM) are environmental pathogens present in the soil and water that can cause
chronic, debilitating disease in predominately older patients with underlying bronchiectasis or chronic obstructive
pulmonary disease. The most common causes of NTM pulmonary disease (NTM-PD) are Mycobacterium avium
complex (MAC) and M. abscessus (MAB). Key symptoms of NTM-PD include cough, extreme fatigue, and
shortness of breath. NTM-PD is heterogeneous in presentation: nodular-bronchiectatic disease (~60-70%) tends
to be slowly progressing and if MAC may not require immediate treatment, while those with cavitary disease
(~25%) or MAB require immediate treatment. Multi-drug therapy, when initiated, consists of 3-5 antibiotics taken
for 18+ months. NTM treatment carries risks of significant toxicity and is poorly tolerated by some patients.
Although most patients have microbiologic response to treatment, many are unable to produce sputum for
testing, and treatment success is evaluated as subjective clinical improvement. Changes in cough rates and
patterns are presumed to be important but have not been objectively measured. Further, after completing
treatment, around half will re-develop NTM-PD within 3 years. Unlike its “cousin” tuberculosis where culture
conversion is a surrogate for cure, the meaningfulness of culture conversion to patients in pulmonary NTM is
less clear. Patient-reported outcomes (PROs) which measure symptoms, functioning, and health-related quality
of life are key components of patient-centered research and care. Improvements in daily symptoms and
functioning are critical outcomes from the patient’s perspective, but significant evidence gaps exist in the role of
PRO data to inform decisions about when to treat among those who do not require immediate treatment, how to
measure treatment response and tolerability, and how to monitor patients post-treatment.
We propose to fill critical gaps in knowledge regarding the trajectory of PRO measures for NTM-PD and
incorporate an objective cough monitor to measure rates and patterns of cough in patients. This prospective
cohort study leverages our experience establishing an NTM Clinical Trials Network and Northwest NTM Biobank
data repository. We will continue longstanding collaborations with Drs. Winthrop, Daley, Flume, McShane, and
Aksamit for all proposed aims. During Years 1-4 we will enroll 3 well-characterized cohorts of patients
representing key stages of NTM-PD – initial diagnosis (NTM-WATCH), treatment start (NTM-TREAT), and at
end of treatment (NTM-TRACK) from participating sites and collect PROs and clinical outcome data for up to 24
months for each cohort. During Years 3-5 we will conduct our descriptive and longitudinal analysis of PROs in
these prospective cohorts, evaluating PRO measures’ ability to monitor disease activity and tolerability of
treatment. Our findings will lay the groundwork for future evaluation of combined outcome measures for clinical
trials endpoints and, most importantly, incorporation of PRO measures in clinical practice.

Public health relevance
PROJECT NARRATIVE Chronic nontuberculous mycobacterial (NTM) pulmonary disease is an increasingly common orphan disease that causes progressive disability in older adults. Patient-reported outcome (PRO) measures are a patient- centered way to measure symptoms, functioning, and symptomatic adverse events over time. We seek to understand the trajectory of symptoms and their association with NTM pulmonary disease activity, response, and recurrence after treatment completion.